Preconception periodontitis and adverse pregnancy outcomes in a prospective cohort of pregnancy planners

The prevalence of hypertensive disorders (e.g. gestational hypertension, pre-eclampsia, and eclampsia) and
metabolic disorders (e.g. Gestational Diabetes Mellitus) is high and significantly contribute to maternal
morbidity and mortality. Further, these conditions are primary risk factors for preterm birth and low-birthweight
outcomes, and thus also contribute dramatically to neonatal morbidity and mortality. Given the increasing rates
of these disorders in recent years, and the associated detrimental health outcomes, prevention and early
detection are critical for improving maternal and neonatal outcomes. Systemic inflammation prior to pregnancy
is regarded as a contributing factor in the development of these conditions and outcomes, yet the underlying
causes are mostly unknown. Understanding and addressing sources of systemic inflammation in the
preconception period may hinder the development of hypertensive and metabolic disorders during pregnancy,
as well as reduce the incidence of preterm birth and low birthweight outcomes. Periodontitis is the most
common chronic inflammatory condition among U.S adults, affecting 38% of women aged 30 years and older.
The associations between periodontitis and pregnancy-related conditions and outcomes have been studied in
recent decades. However, results of this work have been mixed, owing to the restricted measurement of
periodontitis during pregnancy, the lack of data on important confounders, and difficulty in obtaining enough
data to provide meaningful, precise results. Through the use of prospective data obtained from PREgnancy
STudy Online (PRESTO), an ongoing internet-based preconception cohort study of nearly 17,000 North
American women planning a pregnancy, this proposal aims to:
1. Estimate the associations between preconception periodontitis and hypertensive and metabolic disorders in
pregnancy, preterm birth, and low birthweight outcomes.
2. Evaluate the validity of the associations through the conduct of probabilistic quantitative bias analyses and
the incorporation of inverse probability weighting to explore the plausibility of alternative explanations for the
observed results (e.g., unmeasured confounding, exposure misclassification bias, and selection bias).
Completion of the proposed aims will enhance our understanding of the role that periodontitis may play in
maternal and neonatal morbidity and mortality and may provide a foundation for mechanistic studies that
elucidate inflammatory pathways underlying these associations. Eventually, this work could lead to therapeutic
interventions to reduce the population-level burden of these serious reproductive health conditions and
outcomes.

Public health relevance
Using prospective data from a large cohort of pregnancy planners, this study aims to understand the role that periodontitis prior to pregnancy may play in maternal and neonatal morbidity and mortality, including hypertensive and metabolic disorders of pregnancy and preterm birth and low birthweight outcomes. In addition to the prospective nature of the study, this project implements probabilistic quantitative bias analysis, inverse probability weighting, and causal mediation analyses in an effort to provide greater insight into the potential for causal associations and the opportunity for future intervention science.